The inflammatory mechanisms underlying olfactory dysfunction in prognosis of TBI progression to dementia

Project Summary
20–68% of traumatic brain injury (TBI) patients exhibit trauma-associated olfactory deficits (OD) which can
compromise not only the quality of life but also cognitive and neuropsychiatric functions. Although post-
traumatic anosmia has been documented in the medical literature for more than a century, neither the
underlying mechanisms nor treatment remain clear. Moreover, the occurrence of TBI significantly increases
risk for the development of Alzheimer’s disease (AD) or non-AD forms of dementia. Recent studies of OD have
focused its potential as an early biomarker for the diagnosis of neurodegenerative disorders and their disease
progression. Thus, TBI survivors with OD may be an early sign heralding its progression to dementia. AD
pathogenesis revealed that the peripheral olfactory pathways including the olfactory bulb (OB) are the potential
structural candidates responsible for OD in prodromal AD. Emerging studies have associated OD with the
presence of OB inflammatory response, suggesting that OB pathology may provide a mechanistic link between
TBI and AD or dementia. Recent data indicate that TBI-induced rapid and persistent pro-inflammatory
responses in the OB were accompanied by increased phosphorylated tau and OB atrophy, resulting in early
and persistent olfactory deficits. New data indicate that microglia-mediated inflammation contributed to
neuronal hyperexcitation in the OB which was mitigated in the absence of Hv1, a newly discovered microglial
ion channel required for NADPH oxidase-dependent generation of reactive oxygen species. Based on these
findings and our preliminary data, we hypothesize that early after TBI microglial Hv1-mediated inflammation in
the OB contributes to hyperexcitation of local neurons leading to olfactory dysfunction, thus heralding its
progression to late-onset neurodegeneration.
With multidisciplinary approaches including the Designer Receptors Exclusively Activated by Designer
Drugs (DREADD)-based chemogenetic inhibition of OB microglia, microglia-specific and inducible Hv1 KO
mice combined with microscopy and biochemical approaches, and comprehensive neurobehavioral testing, we
will examine neuroinflammation and neurodegeneration in the OB in a well-established controlled cortical
impact mouse TBI model and their correlation with OD and late-onset dementia-like behaviors (AIM 1).
Furthermore, powerful in vivo and in vitro electrophysiological approaches will be applied to characterize
detrimental effects of TBI-induced inflammation on network and synaptic functions in the OB (AIM 2). Lastly,
we will determine whether genetic or pharmacological inhibition of inflammatory pathways in the OB through
intranasal delivery mitigates TBI-induced inflammation and neurodegeneration thus improves functional
outcomes (AIM 3).
Our study will be the first to link olfactory dysfunction to dementia and neurodegeneration following TBI.
Our findings will potentially shed light on developing effective approaches for early and accurate diagnosis of
TBI-associated OD in the development of neurodegeneration and dementia.

Public health relevance
Project Narrative Although clinical and experimental studies demonstrate olfactory dysfunction (OD) after traumatic brain injury (TBI), the underlying mechanisms and treatment remain elusive. The aim of our research is to investigate the inflammatory mechanisms underlying OD in a well-established controlled cortical impact mouse TBI model in order to allow future development of early and accurate diagnosis of TBI predisposing to dementia. Elucidating the underlying mechanisms of OD after TBI might be necessary not only to understanding the nature of neurodegeneration but also to developing disease management strategies for treatment and prevention.